Flourish All: Women's Integrated Stress Reduction for Alzheimer's Risk Prevention Using Digital Tools and Biomarker Monitoring

Alzheimer’s disease (AD) and Alzheimer’s Disease-Related Dementias (ADRD)
disproportionately affect women, who account for two-thirds of all AD patients. One critical but
underexplored factor contributing to this disparity is menopause, a life stage experienced by half
of the world’s population. Hormonal changes during menopause, particularly the decline in
estrogen, are linked to increased neuroinflammation, a key driver of ADRD risk.
Postmenopausal women also face heightened vulnerability to stress-related disorders, which
further exacerbate inflammation and cognitive decline. Addressing these factors during
menopause offers a transformative opportunity to reduce ADRD risk. with stress and
inflammation recognized as key risk factors influencing its onset. This project seeks to address
this critical gap through the development and evaluation of the Flourish All platform, an
AI-enabled digital health solution aimed at reducing ADRD risk by managing stress and
promoting healthy behaviors in midlife women. The study will be conducted in two phases:
Phase I (Pilot Study): This phase will focus on usability, acceptability, and feasibility testing
with 40 participants aged 50–70 who exhibit moderate to high perceived stress. Over a 12-week
period, participants will interact with the Flourish All platform, which integrates an AI chatbot,
wearable devices, and at-home biomarker collection kits. Outcomes will include participant
engagement (e.g., ≥3 chatbot interactions per week), usability (>80% of participants rating the
platform as easy to use), and feasibility (>80% provision of usable biomarker and wearable
data). Insights from this pilot will inform iterative refinements to enhance the platform’s usability
and functionality in preparation for larger-scale trials. Phase II (Randomized Controlled Trial):
Building on the pilot findings, a 12-week RCT will be conducted with 120 participants,
randomized into intervention and waitlist control groups. Participants in the intervention group
will engage with the Flourish All platform to receive personalized, AI-driven recommendations
targeting stress reduction, physical activity, and sleep quality. Data collection will occur at
baseline, immediately post-intervention, and at 3- and 6-month follow-ups. The efficacy of the
platform will be assessed through primary outcomes, including reductions in perceived stress
(PSS scores) and inflammation biomarkers (CRP, IL-6). Secondary outcomes include improved
sleep quality, cognitive function (MMSE, ADAS-Cog, ECog), and physical activity. Longitudinal
data will enable the development of predictive AI models linking stress reduction to changes in
AD risk markers and cognitive performance.

Public health relevance
This project addresses the urgent need for scalable, evidence-based interventions to reduce Alzheimer’s disease (AD) and Alzheimer’s Disease-Related Dementias (ADRD) risk in women. Leveraging biomarkers, wearable devices, and psychosocial surveys, the Flourish All platform delivers real-time monitoring, personalized feedback, and actionable insights for women age 50+. By integrating an AI-enhanced digital health platform, with personalized stress reduction interventions targeting negative thinking patterns, sleep quality, and physical activity, this study seeks to mitigate key modifiable risk factors for AD/ADRD.